The Nomenclature of Human and Vertebrate Genes

PROJECT SUMMARY (HG003345)
Naming systems are crucial in all walks of life, especially in science and clinical medicine where accuracy and
reproducibility are vital. The HUGO Gene Nomenclature Committee (HGNC) is the only group worldwide that
has provided standardized naming for human genes. HGNC’s symbols, names and identification numbers
(IDs) enable effective communication and exchange of information between anyone interested in genes. The
first aim of this application carries on this crucial work, focussing on naming newly identified protein coding loci,
both within the current reference genome and in new pangenome haplotypes, and continuing systematic
naming of pseudogenes and RNA genes. Utilizing data arising from a variety of methods including deep
learning we will continue to update nomenclature for newly characterised loci, genes with uninformative
placeholder symbols, and in rare cases where existing nomenclature is proven to be misleading. This aim also
recognises the need for stability in nomenclature, especially for genes associated with phenotypes. HGNC will
review protein coding genes with informative names and aim to stabilize symbols for the majority of well
characterized genes. Aim 2 will expand into the field of transcript naming; to date this has been restricted to a
very small set of complex loci (e.g. protocadherins). In collaboration with the biocuration groups from NCBI and
EMBL-EBI, HGNC will work with the community to establish guidelines for transcript naming, and provide
standardized names (and stable HGNC IDs) for well-defined transcripts. Aim 3 will pursue HGNC’s role in
coordinating gene naming across vertebrates, through collaboration with the existing nomenclature committees
for mouse, rat, chicken, Xenopus and zebrafish, and through work as the Vertebrate Gene Nomenclature
Committee (VGNC). Established by the HGNC in 2016, to date the VGNC has named over 112,000 genes
across key species (chimpanzee, macaque, cattle, pig, horse, dog, cat), using a combination of automation
and manual curation. These efforts will be broadened to include naming in Chiroptera from the Bat 1K project,
both to expand VGNC’s taxonomic range and due to their intriguing antiviral immune responses. Building on
the HGNC and VGNC’s existing gene group resources, and in collaboration with experts, gene nomenclature
will be standardized across vertebrates in complex families including the C2H2 zinc fingers, immunity related
genes such as the MHC locus, and pharmacogenetically relevant genes. This aim will include development of
a pipeline for phylogenetic and syntenic analysis in complex families. In Aim 4 HGNC will engage with
stakeholders to encourage compliance with approved gene nomenclature, working with journal editors and
publishers. Awareness of HGNC’s resources, especially within the clinical community, will be raised via direct
engagement, and through channels such as Twitter/X and the genenames.org blog, while the number of video
tutorials will be expanded. The use of approved nomenclature is vital to avoid confusion and wasted
experiments in the laboratory, and to reduce the potential for patient harm.

Public health relevance
PROJECT NARRATIVE (HG003345) The HUGO Gene Nomenclature Committee (HGNC) is the only organisation worldwide that provides official unique symbols and names for all human genes, and coordinates gene naming across vertebrate species. Standardized gene naming is an essential component of genomics, and hence a key feature of the infrastructure of biomedical research that must be actively maintained and updated. The HGNC's resources accelerate science by providing a common language to discuss genes; as genomic medicine becomes mainstream, the need for this common language becomes ever more vital.